Alteration and Renovation

Abstract
One mission of NH-INBRE is to increase the amount, sophistication and impact of
biomedical research at institutions of higher learning in New Hampshire. A key step
in accomplishing this is to expand modern laboratory space at our PUI Partners.
Prior renovation funding has done that and the current proposal again has that goal.
In the inaugural phase of NH-INBRE the funding for alterations and renovations was
used to create two dedicated research laboratories at PUI Partner institutions. This
was very successful, as the labs have been used by what have become two of our
most active NH-INBRE investigators, as well as the large cadre of student
researchers they have included in their research efforts over the past 14 years.
Building upon this successful model the renovations funded in our first competing
renewal were used to further expand research space for the growing research-
engaged faculty at 3 PUI Partners during the second INBRE award period. We now
propose to create and upgrade more lab space at two PUI Partner institutions. As
was the case with previous renovations, the labs that the proposed alterations and
renovations will create are essential for investigators at these Partners to have
sufficient space to pursue research and meet the increasing demand for research
experiences coming from undergraduates.
Plans were developed and selected in an open, competitive process that included
donated time and effort from Dartmouth Facilities Office current and previous
personnel and experienced professional contractors. Partners receiving renovation
support significantly cost-share needed funding. When completed, the proposed
renovations will increase the number of faculty members who can be active
investigators and increase the number of student researchers with these faculty
mentors, as well as an increase the research capabilities and resources at these
NH-INBRE Partner institutions. On a broader scale, expanded research labs will
make significant contributions to the development of a vibrant and visible research
culture at these Partners.